Shared Resource Management

PROJECT SUMMARY/ABSTRACT
Perlmutter Cancer Center Shared Resources Management (PCCSRM) provides centralized oversight of the
eleven (11) Perlmutter Cancer Center Shared Resources (PCCSR): the Applied Bioinformatics Laboratories,
Biostatistics, Center for Biospecimen Research and Development, Experimental Pathology, Genome
Technology Center, Immune Monitoring Laboratory, Metabolomics Laboratory, Microscopy Laboratory,
Proteomics Resource Laboratory, Preclinical Imaging, and Rodent Genetic Engineering Laboratory. Each
PCCSR is led by a PCC Shared Resource Director (PCCSRD), all of whom are NYU Grossman School of
Medicine (NYUGSoM) faculty members, experts in their fields, and integral intellectual partners in Perlmutter
Cancer Center (PCC) research projects from experimental design to assay development to data analysis.
PCCSR deliver state-of-the-art services, develop and implement innovative methods and technologies, and are
highly integrated and collaborative, enabling projects that require coordination of diverse technologies. They are
heavily used by, and essential, to the four PCC Research Programs: nearly 70% (318) of all PCC publications
during this funding period used at least one PCCSR. PCCSR are institutional resources of NYUGSoM, are
supported by “chargeback” revenues and generous institutional subsidies and are tracked via a custom
dashboard and iLabs. From 2018-2022, institutional investment in PCCSR was $46,179,896. PCCSR are led
by Adriana Heguy, PhD, PCC Associate Director for Shared Resources. Heguy and her management team of
administrators and PCCSRD continually assess the needs of PCC Research Programs via surveys and advisory
board meetings. This oversight ensures that PCCSR services are high-quality and cost-effective, that access to
services is equitable, that each shared resource (SR) provides training in key technologies to PCC members
and their laboratories, that new SRs are developed when appropriate, and that underutilized or obsolete SRs
are closed. PCCSRM continuously plans for the acquisition and implementation of new technologies and
presents those plans to PCC and NYGSoM leadership to ensure continued investment in instrumentation and
infrastructure for PCCSR. The Specific Aims of PCCSRM are: 1) To provide centralized infrastructure to ensure
that all shared resources meet or exceed the expectations of investigators and support the multidisciplinary
research mission of PCC, 2) To develop and support transparent mechanisms that educate, engage, and train
PCC investigators in innovative technologies, experimental design, and ensuring data provenance, 3) To
promote and facilitate research collaborations between the four PCC Research Programs and support best
practices for data management and sharing for scientific rigor and transparency, and 4) To continuously assess
the service needs of PCC members and interact with PCC and NYUGSoM leadership to ensure continued
investment in instrumentation and infrastructure required to support basic, translational, and research